CCB SPECIAL INTEREST GROUP ON MULTI-RESOLUTION REPRESENTATION OF

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. "CCB Special Interest Group on Multi-Resolution Representation of Biological Shape" To develop the framework for efficient and robust representation of biological shape, form and size (e.g., cortical surfaces) using wavelet-based multi-resolution techniques.